Aging Neural Systems and Communication Difficulties

PROJECT SUMMARY/ABSTRACT
Age-related speech recognition difficulty and its association with poorer memory, increased fatigue, social
isolation, and cognitive decline are major public health concerns with the current aging population. Older adults
consistently show increased listening difficulties compared to younger adults, including poorer understanding
and memory for speech in noise. The long-term objective of this research is to investigate age-related brain
differences that affect (1) how quickly and (2) how much information is used during the perceptual recognition
of speech in noise. We will use a perceptual decision-making framework to characterize differences in the
speed of evidence accumulation and height of decision criteria, which can affect the accuracy and latency of
speech recognition. Older adults appear to accumulate evidence more slowly and use more cautious decision
criteria than younger adults. Brain imaging studies have linked evidence accumulation and decision criteria-
setting to distinct brain systems, which also decline with older age. However, the contribution of perceptual
decision-making to age-related listening difficulties is not yet known. The interrelated Aims 1-2 for the current
research will test the overarching hypothesis that age-related declines in perceptual decision-making
processes limit understanding and memory for speech in noise, commonly observed for older adults. The Aim
1 neuroimaging experiments manipulate how quickly evidence accumulates, to characterize the degree to
which older adults accumulate evidence more slowly than younger adults based on uncertain and noisy
sensory information. We predict that slower evidence accumulation measures are associated with poorer
understanding and delayed recognition memory for older adults compared to younger adults. Structural
diffusion imaging data will be collected for white matter tracts to determine whether declines in the connections
between brain regions are associated with slower evidence accumulation. The Aim 2 neuroimaging
experiments manipulate decision criteria, to characterize age-related differences in how much evidence is
collected in challenging listening conditions. Older adults often respond more slowly and cautiously in noisy
conditions compared to younger adults, regardless of task difficulty. Older adults also demonstrate poorer
memory for targets and better recognition of distractors than younger adults. We predict that decision criteria
variation will be associated with poorer understanding and memory for speech in noise. Structural gray matter
measures will be collected to examine neural declines accounting for age-related differences in decision
criteria, given that frontal brain regions linked to criteria show lower volume for many older adults. Perceptual
decision-making can explain differences in speech recognition performance outside of the neuroimaging
environment, so this research is a critical first step to developing measures to characterize an individual's
listening difficulties and guiding effective rehabilitation strategies.

Public health relevance
PROJECT NARRATIVE Understanding why speech recognition is slower for older adults than younger adults could help address common age-related listening and memory difficulties. Our research examines how quickly information is collected and how much information is needed for speech to be understood in noise. We will study the brain systems that support recognition of words based on incomplete fragments to better understand why word recognition is slower for many older adults.